COMMUNITY BASED NUTRITION EDUCATION FOR HISPANICS

The aim of this proposal is to fully develop the successful phase I Hispanic community nutrition pilot program to encourage healthy cooking of traditional dishes. As in Phase I, social marketing will be used as a referent from which to design, implement, evaluate, and manage a more complex intervention effort to increase the potential reach and effectiveness of the messages, procedures, and services, as well as its receptivity by the Hispanic community.